Community Engagement Core

COMMUNITY ENGAGEMENT CORE: PROJECT SUMMARY/ABSTRACT
The Community Engagement Core (CEC) supports the mission of the Southern California Environmental Health
Sciences Center (SCEHSC) through engagement of community partners in a collaborative multidirectional
process to identify and address the effects of the environment on human health in Southern California (CA). The
CEC serves as a national leader in and model for engagement with communities—especially those which consist
primarily of Latinx, Asian/Pacific Islander and African-Americans living under economic hardship and facing
disproportionate adverse health outcomes from social and environmental disparities. The CEC primary target
audiences include communities, primarily reached through community-based organizations, together with
policymakers and health professionals to address: (a) transportation-related air pollution and impacts on health,
which has evolved directly from key SCEHSC research findings showing air pollution to be one of Southern CA’s
leading environmental health issues; (b) concerns about health impacts from goods movement facilities,
including marine ports, railyards and inland warehouses; and (c) broader health and emerging air quality
concerns arising from land-use decisions such as locating industries adjacent to homes and schools across the
multiethnic landscape. Over the past 24 years, the CEC has developed a successful model to listen to the
community and engage community-based organizations and decision-makers in addressing environmental
health disparities related to traffic and goods movement in Southern CA. During the current cycle, we built on
this approach to integrate novel methods to train residents and health professionals in participatory air
monitoring, to collaborate with multiple stakeholders to assess and reduce toxic air emissions at a neighborhood
scale, and to expand our engagement program to address growing concerns around industrial facilities across
the region. We leverage traditional and nontraditional communications techniques such as digital StoryMaps,
social media, and infographics to update stakeholders on current science and engage the power of communities
to reduce EH burdens. In this next cycle we aim to: 1) Facilitate a multidirectional communication structure that
fosters interaction, share SCEHSC research findings and engagement models with local/regional/national
audiences, and increase SCEHSC investigators’ understanding of community concerns with guidance from our
community advisors; 2) Build capacity of community organizations from environmental health disparity
populations to respond to environmental health burdens and to address those burdens through community
science and public policy; 3) Disseminate SCEHSC research findings to local & national audiences by utilizing
innovative communication methods, tailoring print and web-based materials and resources for intended
audiences, and amplifying our reach through social media, and 4) Evaluate the success of CEC activities through
logic models and formative and summative evaluations.